THIS IS A 12-MONTH DIRECT OFFER, TIME-AND-MATERIALS (T&M) TASK ORDER FOR RESEARCH DATA MANAGEMENT & REPORTING (RDMR) SUPPORT SERVICES IN ACCORDANCE WITH THE UNDERLYING BPA (75N96023A00001) AND THE ATT

The Chemical Effects in Biological Systems database (CEBS) hosts extensive toxicology study results and metadata from the NIEHS Division of Translational Toxicology (DTT) and other studies of environmental health interest. This resource grants public access to search and collate data from multiple studies of various test articles (chemicals, environmental agents). Research data from these diverse studies and other sources are being generated at an ever‐increasing rate, via rapidly evolving methods, study designs, and technologies. The overarching objective of this contract is to ensure that Environmental Health Data from DTT and other sources are managed accurately and made available to the public securely, in context, completely and correctly as directed by the Government.

Public health relevance
The work performed under this contract involves data integration across multiple toxicology studies and domains and the presentation of these data in meaningful and accurate formats for use in public health decision‐making.